Macrophage nuclear receptors, metabolism and immune effectors during health and M. tuberculosis infection

Project Summary/Abstract
Resident alveolar macrophages (AMs) possess a unique, highly regulated immune response that remains poorly
understood, especially for human AMs (HAMs). Failure to understand the molecular events underlying AM
development & biology creates a critical barrier to developing new treatment strategies effective in the lung. The
overall goal of this ongoing research program is to identify transcriptional regulators and pathways that
dictate AM immunobiology and how these are co-opted by the host-adapted intracellular pathogen
Mycobacterium tuberculosis (M.tb) to enable its survival. In the last grant cycle, the lab developed the first HAM
model (alveolar macrophage-like cells, AMLs) that possesses many key features of HAMs. Armed with this new
model, we aim to continue our studies of nuclear receptor (NR) function in human macrophages. NRs are critical
sensors & regulators of immune functions in macrophages and other cell types. Previous grant cycle work has
identified MCL-1 as an effector of the NR peroxisome proliferator-activated receptor gamma (PPAR) that is
critical for M.tb growth. Combination preclinical MCL-1 & BCL-2 inhibitors robustly inhibits drug-sensitive and -
resistant M.tb growth in human macrophages and a human in vitro granuloma model, demonstrating the potential
efficacy of a targeted host-directed therapy (HDT) for tuberculosis (TB). Building on this success, we have now
identified an emerging NR family (NR4A1,2&3), whose expression, similar to PPAR, swiftly declines after AM
removal from the lung, indicating a role for the NR4A family in AM phenotype & function. Thus, the NR4A family
and their downstream effectors may represent a new frontier for HDT approaches for TB. Our preliminary data
indicate that NR4As are important for control of M.tb in macrophages, epithelial cells, a lung on chip (LoC) model,
and in vivo in mice, and therefore may oppose PPARactivity in balancing AM immune responses. Exciting new
data show that key macrophage pathways in M.tb pathogenesis regulated by NR4As include Type I interferon
(IFN) signaling & apoptosis. We hypothesize that lung-specific activation of NR4A family members dampens
Type I IFNs and drives apoptosis to control M.tb growth. The Specific Aims are to: 1) define the roles of NR4A
family members in regulating Type I IFN-mediated responses and apoptosis during M.tb infection in vitro, 2)
elucidate the protective role of NR4As in vivo using M.tb mouse models, and 3) identify novel compounds that
target NR4As as potential HDTs for M.tb. HAMs, AMLs, LoC, human granuloma and mouse models will be used
to define the role of NR4As & PPAR during M.tb infection using biochemical, in silico, next generation
sequencing and cellular immunology techniques. Since these NRs operate in a tissue, gene and signal-specific
manner, these findings open the door to a completely new set of biological pathways likely to be critical to host
responses in the lung during health and M.tb infection, and will aid in developing HDTs for TB, a leading cause
of death.

Public health relevance
Project Narrative Tuberculosis (TB) is a massive global health burden and leading cause of death worldwide with a significant level of resistance to current antibiotics. It remains unclear why macrophages in the small airspaces of the lungs (alveolar macrophages, AMs) are unable to control airborne M. tuberculosis and thus, we seek to fill this gap by studying proteins that regulate AM immune responses and are bona fide host cell drug targets using the first accessible human AM tissue culture model (AMLs), a novel lung-on-chip model that includes AMLs, and mice. Increased understanding of why AMs are susceptible to M. tuberculosis is expected to aid in the development of targeted host-directed therapies active in the lung for drug susceptible and resistant TB.